Statistical and Data Coordinating Center: SARS-CoV-2/COVID-19 Clinical Trial Support for research activities

The goal of the Statistical and Data Coordinating Center is to provide comprehensive statistical support, data management and analysis activities for DMID-sponsored COVID clinical research trials. This includes internet-based electronic data collection, data management, data quality control and a specimen tracking system. In addition, the contractor provides consultation on statistics, study design, appropriate control groups, sample size, power calculations, randomization, stratification, and analysis.